A Test for Heavy Alcohol Consumption in First Episode Coronary Heart Disease

Excessive alcohol consumption (EAC) is often a silent killer that manifests its deleterious effects through its
effects through other disease processes. Heavy alcohol consumption (HAC), which we define as drinking 6 or
more drinks per day, is probably the best studied form of EAC and is a known to be substantial risk factor for
CHD. But the exact frequency of HAC in those with CHD and the relationship of lesser levels of alcohol
consumption to risk for CHD is not well established. However, if EAC is significantly contributing to the
pathogenesis of CHD, quantifying then addressing EAC in clinical treatment plans may be critical for the
prevention of the alcohol induced CHD deaths.
Recently, we have developed an epigenetic tool known as the Alcohol T Score (ATS) to quantify steady
state alcohol consumption. Using this tool, we show that in young adults, ATS values predict a large portion of
the variance for developing the epigenetic signature of CHD. Then, in a second set of older adults with acute
coronary syndrome (ACS), we show that ATS levels significantly predict survival (p<0.02) with those at the 90th
percentile of ATS values being 2.4 fold more likely to die in the follow-up period than those at the 10th
percentile of ATS values. In essence, these findings show that ATS values predict the development of CHD
and death in those with CHD, but do they predict CHD itself? If so, this suggests that clinicians could prevent
perhaps as many as 25% of all cardiac deaths by simply treating EAC before the first heart attack.
Therefore, in this R43, we plan on extending our examinations to those with new onset CHD. Specifically,
we hypothesize that HAC is more frequent in those with first episode CHD. To test that hypothesis, we will
examine ATS, ZSCAN25 and phosphatidylethanolamine (PEth) levels in those with first episode CHD. We will
then compare those levels to those in 75 age and sex matched controls to determine whether HAC is more
frequent in those with new onset CHD. This project is innovative because excessive alcohol consumption is
generally not considered in assessment of new onset CHD. It is high impact because HAC may be a significant
contributor to related morbidity and mortality at all stages of CHD. The team is well prepared to conduct the
research and includes board-certified cardiologist, statisticians and a leading expert on DNA methylation. The
institution at which the study will be based evaluates thousands of patients annually for new onset CHD and
Behavioral Diagnostics controls the IP for this technology which includes recently filed claims for this specific
purpose. As a direct result of this research, we will determine whether new onset CHD is associated with HAC.
As an indirect outcome, we will demonstrate the potential value of DNA methylation assessments of alcohol
consumption as part of routine primary and secondary prevention assessments of cardiovascular disease. If the
value of the testing appears significant, this will set up an R44 to determine the utility of our epigenetic alcohol
testing for in routine assessments of CHD.

Public health relevance
Narrative The purpose of this test is to determine whether values for a test of chronic alcohol consumption are elevated in those with the onset of CHD.